Dithiolopyrrolone Antibiotics: Biosynthesis, Mode of Action and Cellular Function

Project Summary Dithiolopyrrolone antibiotics share a unique disulfide-bridged heterobicyclic core and exhibit potent activities against bacteria, fungi, and mammalian cancer cell lines. Although the dithiolopyrrolones have been known for over sixty years, their therapeutic mode of action, biosynthesis, and physiological functions are not well understood. A genome-mining approach was used to identify the biosynthetic gene cluster of a particular dithiolopyrrolone compound, holomycin, in its producing strain, Streptomyces clavuligerus. This preliminary work established the foundation for more intensive investigations of the dithiolopyrrolone scaffold, described herein. This proposal includes three specific aims: 1) Elucidating the modes of action of dithiolopyrrolones including holomycin. Holomycin is hypothesized to exert its activity through redox cycling and/or protein modification. A systems biology approach will be undertaken to group holomycin with antibiotics with known mechanisms of action. In conjunction, transcriptional profiling studies of holomycin-treated bacteria will be carried out to further provide clues regarding the mode of action. Pull down experiments will also be performed in bacterial culture to identify the molecular target(s) and chemical reactivity of holomycin; 2) Investigating the biosynthetic pathway of dithiolopyrrolones. In-depth characterization of the order and mechanisms of individual enzymatic transformations will be carried out regarding the holomycin biosynthetic pathway, in particular the redox chemistry involved in the oxidation steps and bicyclic ring formation. Further, a genome-mining approach will be utilized to uncover unknown dithiolopyrrolone gene clusters and novel dithiolopyrrolone compounds; 3) Scrutinizing the functions and regulatory mechanisms of holomycin in Streptomyces. Though identified as antibiotics and anticancer molecules, dithiolopyrrolones are hypothesized to serve as signaling molecules for their producing organisms. Transcriptional profiling studies will be undertaken to examine the effects of holomycin in S. clavuligerus and model Streptomyces strain, S. coelicolor. The regulatory mechanism of holomycin production will be explored through transcriptional analysis and genetic manipulation of the regulatory genes present in the cluster. The studies described in this proposal will significantly advance our understanding of Nature's logic to assemble dithiolopyrrolones and their mechanisms of action, provide new ways to convert them into viable therapeutics for cancer and infectious diseases, and shed light on the intricate regulatory network of secondary metabolites in Streptomyces, the industrial workhorses accounting for a large number of drugs in current use.

Public health relevance
Project Narrative Studies in natural products have proven fertile ground for discovery and design of novel pharmaceuticals. The proposed research on the dithiolopyrrolone antibiotics, a unique group of natural products, will afford new ways to generate these antibiotics, and provide basis for future efforts to improve their pharmacological effects in treating infectious diseases and cancer. Further, the dithiolopyrrolone-producing microorganisms generate a large wealth of natural products, and a deeper understanding of these microorganisms will build foundation for the discovery of novel therapeutics. __SpecificAimsTextDelimiter__ Specific Aims. Dithiolopyrrolone Antibiotics: Biosynthesis, Mode of Action and Cellular Function Summary: This proposal illustrates a research trajectory to investigate the antimicrobial mode of actions, biosynthesis, and intrinsic physiological functions of dithiolopyrrolone antibiotics. This class of antibiotics is broadly distributed and appears to have a diverse range of biological functions. The structure of the highly oxidized scaffold suggests a unique redox activation mechanism for antibiotic activity, while our preliminary data indicate that this class of molecules also has a signaling role in the Streptomyces producer. A representative dithiolopyrrolone holomycin will be the primary focus of investigation during Dithiolopyrrolone the first phase of the proposal. I have recently identified the gene cluster of holomycin from core highlighted O Streptomyces clavuligerus, and I will continue to study the biosynthesis of this molecule H under the guidance of Prof. Christopher Walsh (Specific Aim 2). However, a second phase of N NH study and my primary focus of the proposed K99 phase will be to investigate the mechanisms O of action of holomycin (Specific Aim 1), which will provide initial findings for further in-depth S S studies in the R00 phase. This work and requisite training will be carried out under the Holomycin guidance of a new co-mentor, Prof. Roberto Kolter at Harvard Medical School. This training period will allow me to gain firsthand experience in microbial genetics and master necessary skills. Most importantly, training with two superb senior advisors, each a leader in their field, will facilitate my interdisciplinary thinking across biochemistry, microbiology and genetics. The training received during the K99 phase will be essential for me to pursue initiatives planed for the independent phase involving the investigation of the function of holomycin and its impact on secondary metabolic networks in Streptomyces (Specific aim 3). Given that the related redox activated antibiotic FK228 has recently been identified as a potent anticancer agent, the dithiolopyrrolones are a promising class of compounds to be investigated for their potential as human therapeutics. Studies proposed in this K99/R00 proposal on elucidation of the mechanisms of action, biosynthesis, native function and regulation of dithiolopyrrolones will provide key insight in this widely distributed and promising class of antibiotics. (K99 develop into R00 phase) Specific Aim 1: Elucidating the mode of action of holomycin and other dithiolopyrrolones. Holomycin has been shown previously to inhibit RNA synthesis in vivo in bacteria, but displays very little effect in vitro against RNA polymerase. The elusive mode of action of holomycin will be the primary focus of the K99 phase investigations. I will test whether holomycin indeed targets RNA synthesis from a systems biology approach with the help of Prof. Roy Kishony in the Dept of Systems Biology at HMS. I also plan to investigate the change in gene expression in the model organisms E. coli and B. subtilis upon holomycin treatment by transcriptional profiling, which will provide clues in regards to the potential targets of holomycin. The redox reactivity of holomycin will also be explored in a cellular environment via a proteomics approach using affinity tagged or radio labeled holomycin. In the R00 phase, I will follow up on the preliminary findings of my initial studies in the K99 phase with in depth investigations using the skills I learn during the K99 phase as well as expansion to other members of the dithiolopyrrolone antibiotics family. (K99 phase) Specific Aim 2: Investigating the biosynthetic pathway of dithiolopyrrolones. I will explore the chemical and enzymology rationale of the biosynthesis of the dithiolopyrrolone antibiotics in a combination of biochemistry and bioinformatics methods. I will begin with holomycin biosynthetic pathway, which contains four flavin-dependent enzymes involved in building the usual dithiolopyrrolone structure. The mechanisms of these enzymes will be studied in detail using purified enzymes and synthetic or enzymatically prepared substrates. This part will be entirely carried out in the K99 phase, and homologous gene clusters that I discover through bioinformatics searches will be studied in the R00 phase to discover novel dithiolopyrrolone compounds along with engineering studies to generate analogs for structure-function relationship studies. (R00 phase) Specific Aim 3: Scrutinizing the functions and regulatory mechanisms of holomycin in Streptomyces. Many secondary metabolites display roles other than self-defense in the producing organisms. I have observed that holomycin influenced the development of its producing strain S. clavuligerus and the model Streptomyces strain S. coelicolor. I hypothesize that dithiolopyrrolones containing the cyclic disulfide group may act as signaling molecules coupled to oxidative stress response. Transcriptional profiling studies will be carried out to detect transcriptional changes of genes in both Streptomyces strains to determine the developmental pathway(s) affected by holomycin. Furthermore, I propose to investigate the regulatory mechanisms of holomycin biosynthesis in relation to other secondary metabolite pathways in S. clavuligerus using a variety of genetics tools that I will learn at John Innes Centre. I will begin by studying the two regulators encoded in the holomycin gene cluster to identify possible DNA targets in the genome in conjugation with affinity labeling of the holomycin promoters to pull down additional regulators. This specific aim will be initiated in the K99 phase, mainly carried out in the R00 phase, and transitioned to a R01 application in 2-3 years.